Role of estrogen receptor-a in aging and sex-specific responses to 17a-estradiol

PROJECT SUMMARY/ABSTRACT
Several pharmacological compounds have shown promise as interventional strategies for extending longevity.
One recently studied compound shown to improve healthspan and longevity is 17α-estradiol (17α-E2). 17α-E2
is a diastereomer of 17β-estradiol (17β-E2) with considerably less binding affinity for classical estrogen receptors
than 17β-E2. The NIA Interventions Testing Program has shown that 17α-E2 extends lifespan in male, but not
female, mice at two doses. The mechanisms that promote sexually divergent responses to 17α-E2 are poorly
understood and are aligned with the increasing recognition that aging and the incidence of specific diseases
often differ between the sexes. This project will explore potential mechanisms by which 17α-E2 modulates aging
and metabolism in a sex-specific manner. Successful completion of this project will determine: 1) if estrogen
receptor α (ERα) is required for 17α-E2 to elicit benefits on healthspan, disease pathology, and lifespan, 2) if
17α-E2 modulates metabolic parameters predominantly through hypothalamic ERα-mediated signaling, 3) if the
beneficial effects of 17α-E2 on metabolic parameters can be mimicked by activating hypothalamic ERα through
chemogenetic approaches, and 4) if the elimination of endogenous estrogen production render female mice
responsive to 17α-E2-mediated effects on metabolism, and if this is ERα dependent. We hypothesize that 17α-
E2 signals through ERα in male mice to enhance healthspan and longevity and that these effects are at least
partially mediated through the hypothalamus. We also hypothesize that female mice lacking endogenous
estrogens will beneficially respond to 17α-E2 in an ERα-dependent manner. Aim 1: Determine if 17α-E2
improves healthspan and lifespan in an ERα-dependent manner. We will evaluate the effects of chronic 17α-E2
treatment on indices of healthspan and lifespan in wild-type and global ERαKO mice. Aim 2: Determine if 17α-
E2 elicits metabolic benefits through ERα in the hypothalamus. We will evaluate the effects of 17α-E2 treatment
on metabolic and healthspan parameters in mice with a hypothalamus-specific deletion of ERα using stereotaxic
delivery of adeno-associated virus (AAV) that drives expression of Cre in ERα-flox mice. Aim 3: Determine if
chemogenetic activation of hypothalamic ERα-expressing cells can mimic the health benefits observed with 17α-
E2 treatment. We will evaluate the effects of stimulating hypothalamic ERα-expressing cells on metabolic and
healthspan outcomes via site-specific expression of AAV Gq-coupled Designer Receptors Exclusively Activated
by Designer Drugs (DREADDs) in ERα-flox mice. Aim 4: Determine if the elimination of endogenous estrogen
production renders female mice responsive to 17α-E2 treatment. We will evaluate the effects of 17α-E2 treatment
on metabolic and healthspan parameters in wild-type and global ERαKO female mice undergoing ovariectomy
or 4-vinylcyclohexene diepoxide-induced ovarian insufficiency. The ultimate goal of this research is to develop
sex-specific pharmacological interventions for attenuating aging and chronic diseases.

Public health relevance
PROJECT NARRATIVE The overall goal of this project is to determine what role estrogen receptor α plays in determining lifespan, healthspan, disease burden, and responsiveness to 17α-estradiol, a lifespan-extending compound, in both male and female mice. We will study the effects of whole body and hypothalamic-specific ablation of estrogen receptor α, the stimulation of estrogen receptor α containing cells in the hypothalamus, and the ablation of endogenous estrogen production. This project will provide significant insight into sexually divergent mechanisms of aging, which is currently a critical barrier to developing sex-specific novel treatments aimed at combating aging and chronic diseases in humans.